Targeted Arf1 inhibition to enhance immune response in oral cancer

PROJECT SUMMARY
Oral cancer is a highly aggressive and devastating malignancy with a poor prognosis at the advanced stage,
resulting in ~300,000 deaths each year worldwide. Currently no effective targeted therapies are available for oral
cancer; thus, there remains an urgent need to develop new therapeutic options to prevent and treat oral cancer.
ADP-ribosylation factor 1 (Arf1) is a member of the Ras superfamily of small GTPases playing a major role in
vesicular trafficking. Arf1 is highly expressed and hyperactivated in oral cancer, where it functions as an
oncogenic driver to favor cancer development and progression. As a critical step in the functional cycle of Arf
GTPases is their activation by guanine-nucleotide exchange factors (ArfGEFs), interrupting the protein-protein
interaction between Arf1 and its specific Arf1GEFs remains an attractive strategy to block Arf1 signaling.
Recently, we have discovered a novel Arf1 inhibitory compound 10b (AI10b) that can structurally mimic the
intrinsic autoinhibitory segment of Arf1GEFs to selectively block Arf1 activation without affecting other Arf family
members. AI10b exhibits a superior anticancer activity in oral cancer cells than other existing Arf1 inhibitors with
no apparent toxicity against normal oral keratinocytes, holding promise to be developed into a safe and effective
targeted therapy for oral cancer patients. Intriguingly, AI10b induces oral cancer cell pyroptosis, a highly
immunogenic form of cell death, and this process requires the cleavage of gasdermin D (GSDMD). Moreover,
AI10b-mediated regression of GSDMD-positive (GSDMD+) oral tumors is markedly impaired in T cell-deficient
TCRαKO mice and CD8+ T cell-depleted C57BL/6 mice, suggesting the requirement of CD8+ T cells for a
prolonged immune response to AI10b. These novel and significant findings inform our central hypothesis that
AI10b can, in addition to its direct cytotoxic effect, trigger host antitumor immunity to eliminate oral tumors. To
test this, there are three Specific Aims: (1) to elucidate the mechanisms underlying AI10b-mediated pyroptosis
in oral tumors; (2) to dissect the mechanisms by which AI10b-induced oral cancer cell pyroptosis potentiates
antitumor CD8+ T cell immunity; and (3) to develop GSDMD-based differential strategies to augment the efficacy
of AI10b in oral tumors. We will integrate cutting-edge techniques in cancer biology and immunology to attain
our objectives, with a long-term goal to improve the therapeutic efficacy of targeted oral cancer therapy. The
success of this project would be a breakthrough in discovering an impactful treatment that can preferentially
target oral or other tumors with hyperactive Arf1 signaling.

Public health relevance
PROJECT NARRATIVE Arf1 is one of the molecular determinants driving oral cancer development and progression. We propose a novel and more effective Arf1-targeted therapy that can simultaneously inhibit tumor survival and promote antitumor immune response. The successful completion of this project will lay a scientific foundation for the design and execution of Arf1 selective inhibitors and offer new opportunities to revitalize targeted treatment for patients with advanced HPV-unrelated oral cancer.